MFAP5 and Skin Scar Formation

PROJECT SUMMARY
This application proposes a customized research training plan designed to promote the development of the
applicant into an independent investigator. The plan includes advanced training in both bioinformatics and
laboratory experimentation, along with tailored professional and career development opportunities. The training
plan is supported by the outstanding availability of local and institutional resources at UIC. The proposed
research will examine the mechanisms that control scar formation, a common result of the healing response. In
adults, the outcome of wound repair is almost always a fibrous scar composed of disorganized extracellular
matrix (ECM). Although regulation of scar formation is complex, a key feature is fibroblast (FB) activation,
which generates ECM and contractile forces. Scarring and fibrosis occurs in many tissues and can cause
significant impairments of the organ system affected. Recent studies in our lab have identified a novel FB
function in wounds that may be linked to scar formation. These studies show that wound FBs can act as non-
professional phagocytes and ingest apoptotic cells. Following apoptotic cell engulfment, FBs develop a fibrotic
phenotype with enhanced migration, increased contractility (α-SMA expression), and increased collagen
synthesis. One factor found to be significantly upregulated in fibrotic phagocytic FBs is microfibril-associated
protein 5 (MFAP5 or microfibril-associated glycoprotein 2/MAGP2). MFAP5 influences microfibril function and
can regulate cell signaling pathways. Interestingly, MFAP5 has been linked to fibrosis in several human
diseases, including some cancers and fibrotic diseases. Still, little is known regarding its role in wound healing
and scar formation. Therefore, the goal of this study is to gain a better understanding of the function of MFAP5
in skin healing and scar formation. We hypothesize that upregulation of MFAP5 in the healing skin wound
modifies the FB response and promotes scar formation. In this study, the role of MFAP5 in wound healing
will be investigated in Mfap5-/- mice, a well-established Mfap5 knock out mouse line. The effect of MFAP5 on
FB phenotype will be further investigated in vitro. This proposal will utilize in vivo and in vitro wound healing
assays and advanced bioinformatics techniques. Aim 1 will assess how the loss of MFAP5 affects wound
healing, including scar collagen content and architecture, wound breaking strength, myofibroblast activation,
angiogenesis, and wound closure. Single-cell RNA sequencing will be used to identify the FB subpopulation
that produces MFAP5 during wound healing. Aim 2 will examine how MFAP5 influences FB function and gene
expression by utilizing in vitro wound healing assays as well as bulk RNA-sequencing and functional pathway
analysis. Together, the Aims will lead to a better understanding of the importance of MFAP5 in healing skin
wounds and scar formation. Information gained from the proposed research may lead to the development of
novel therapeutics and/or discovery of a prognostic biomarker for treatment of fibrotic diseases.

Public health relevance
PROJECT NARRATIVE In humans, the outcome of wound healing is often formation of a fibrous scar, which can severely impair the function of the repaired tissue or organ. This proposal will examine how microfibril-associated protein 5 (MFAP5) modifies the fibroblast response in wound repair to promote fibrous scar formation. The proposed studies will lead to a better understanding of the mechanisms by which microfibril-associated proteins and apoptotic cells influence fibroblast function as well as wound healing outcomes and may suggest the development of novel therapeutics to treat fibrotic diseases.